Role of LRP10 in Parkinson's disease and dementia: a knockout mouse model

Project Summary/Abstract
Parkinson's disease (PD), Parkinson’s disease dementia (PDD), and dementia with Lewy bodies (DLB) are the
common neurodegenerative disorders severely affecting the aging population worldwide. PD is recognized as
the most common neurodegenerative movement disorder. Up to 80% of individuals with PD develop cognitive
impairment which progresses into overt dementia, leading to a diagnosis of PDD. DLB accounts for roughly 5%
of dementia cases in elderly people and is associated with severe and widespread pathological findings of
Lewy bodies in the brain, followed by parkinsonism in over 85% of cases. Most patients with PD, PDD and
DLB do not carry mutations in known disease-causing genes. Recently, loss-of-function variants in the low-
density lipoprotein receptor-related protein 10 (LRP10) gene have been associated with PD, PDD, and DLB.
How its loss-of-function is mechanistically involved in the pathogenesis of PD, PDD and DLB and what is the
physiological and pathological role of LRP10 remain largely unknown. No LRP10 animal models have been
developed and characterized. We propose to generate and characterize the first LRP10 knockout (KO) mouse
model. Our preliminary data shows that LRP10 KO mice exhibit both locomotor and cognitive function deficits
and develop a-Synuclein (aSyn) and tau pathology. Proteomic analysis and immunoprecipitation (IP) pulldown
revealed potential LRP10 targets/ interactors. Based on these observations, our hypothesis is that the loss of
LRP10 function causes PD and dementia, which acts through LRP10-specific targets. To test this hypothesis,
we will examine neuroinflammation, synaptic dysfunction, neurodegeneration, and associated cellular and
behavioral deficits with aging in LRP10 KO mice and determine the potential underlying molecular
mechanisms. We anticipate that our work will provide insights in LRP10 physiological functions and
pathological roles, and further provide a common mechanism for the Lewy body disorders (PD, PDD and DLB)
in general.

Public health relevance
Project Narrative Loss-of-function variants in the low-density lipoprotein receptor-related protein 10 (LRP10) gene have been recently associated with Parkinson's disease (PD), Parkinson’s disease dementia (PDD), and dementia with Lewy bodies (DLB), which are the common neurodegenerative disorders severely affecting the aging population worldwide. Characterizing the first LRP10 mouse model and defining the initial molecular mechanism, through which loss of LRP10 induces neurodegeneration and behavioral deficits, will provide insights into LRP10 physiological functions and pathological roles, and further provide a common mechanism for Lewy body disorders (PD, PDD, and DLB) in general.